DOUBLE-BLIND, PLACEBO-CONTROLLED, MULTICENTER STUDY ON SANDOSTATIN

To determine if Sandostatin relieves pain, can be given safely and has prolonged effect on pain relief after treatment has been discontinued in patients with painful chronic pancreatitis.